Theranostic system for targeted, sustained-delivery with quantitative "hot spot" MPI of magnetic extracellular vesicles

Transplantation of therapeutic cells holds great potential to cure or provide relief to various ailments. In
the clinic, cell grafts often perish or cease to function within a short period post-transplantation. An emerging
strategy is the use of extracellular vesicles (EVs) derived from mesenchymal stem cells (MSCs) as an adjuvant
to cell therapy. However, there remain challenges for effective EV delivery to and retention at the target sites,
and the inability to elucidate the biodistribution and pharmacokinetic profiles of EVs using a clinically relevant
tool. Moreover, a few new studies indicated that multiple deliveries of EVs are essential for therapeutic outcomes,
which are hard to accomplish using the current clinical administration routes. We propose to develop theranostic,
injectable microspheroid EV-delivery systems (EVDS) for local, targeted, and sustained-delivery of EVs while
enabling EV tracking in vivo with magnetic particle imaging (MPI). The design of our EVDS is modular where
each main component of the system can be independently modified to suit different purposes. Our interest lies
in pancreatic islet transplantation to treat type 1 and advanced type 2 diabetes. Two designs of EVDS – LipoCap
and MICap – are proposed. LipoCaps (500 μm) can be infused into the liver via the portal vein (a clinically tested
islet transplantation protocol) for co-implantation with islets, or for follow-up doses post-transplantation. MICaps
(900 µm) are appropriate for implant site with larger volumes, such as the intraperitoneal cavity. Both designs
aim to obtain a local, sustained delivery of EVs to islets. LipoCaps and MICaps will be composed of ultrapurified
alginate, an FDA-approved excipient of food, cosmetic and pharmaceutical products. In order to minimize non-
specific uptake by nearby fat and tissues after the release from alginate matrix, EVs will be loaded inside islet-
targeting liposomes prior to alginate encapsulation. This will be achieved by conjugating the liposomes to
exendin-4, a ligand of glucagon-like peptide-1 receptors which are abundantly expressed on the surface of islet
beta cells. In addition, EVs will be labeled with clinical-grade ultrasmall superparamagnetic iron oxide
nanoparticles (USPIO) to facilitate imaging by MPI. MPI is an emerging modality that provides “hot spot”
visualization as well as EV quantification, much alike to PET and SPECT without the use of radioactive agents.
Unlike 1H MRI, background artifacts from blood pools and motion effects are not an issue with MPI. MPI is
reported to be more sensitive than 19F MRI and CT, and therefore may reduce the quantity of labels introduced
into the patients. MPI may inform physicians on the temporal and spatial behavior of EVs which, in turns, may
afford EV therapy to be customized. To systemically investigate the feasibility of the project, three specific aims
are proposed: 1) To synthesize and characterize LipoCaps and MICaps carrying MSC-EVs, and to test their
effects on human islets’ survival and function in vitro; 2) To develop a USPIO-labeling method that will preserve
EV properties while maximizing MPI detection sensitivity; 3) To test if the proposed EVDS can improve islet
survival and function in immunodeficient NU/J mice while being tracked by MPI.

Public health relevance
Transplantation of therapeutic cells to replace damaged tissues holds great potential in treating or providing relief to various illness, such as type 1 and advanced type 2 diabetes, kidney failure and heart disease. At present, cell transplantation is hindered by short-term survival and function of implanted cells and rejection by the patient’s immune system. We propose to develop an adjuvant system using extracellular vesicles (EVs) derived from mesenchymal stem cells to address these impediments in cell transplantation while enabling monitoring of EVs using magnetic particle imaging for adjustment and customization of the adjuvant treatment as needed by individual patients.